Request for Administrative Supplement to GM132610 entitled "Probes and techniques for biological imaging applications"

No changes to Project Summary/Abstract in this supplement

Public health relevance
No changes to Project Narrative in this supplement